Population Modeling of Bladder Cancer Detection and Control

Abstract
Bladder cancer is the second most common genitourinary malignancy in the US with approximately
80,000 new cases and 17,700 deaths each year. It is a heterogeneous set of diseases that range from
locally treatable superficial tumors that are generally not life-threatening but require chronic management,
to advanced disease that requires multimodal invasive treatments and has higher risk of distal metastasis
and death. It is the ninth most expensive cancer overall in the US, and, per diagnosed patient, the most
expensive cancer to manage. Risk factors for bladder cancer broadly include chemical and environmental
exposures such as cigarette smoking and chemical carcinogens that are ingested or found in the
workplace, as well as genetic abnormalities and chronic bladder irritation. Outcomes for bladder cancer
have remained relatively stable in the last two decades. However, opportunities abound to improve the
prevention, detection, and management of bladder cancer. The advent of novel biomarkers, and novel
treatments, including immunotherapies (checkpoint inhibitors), gene therapies, and antibody-drug
conjugates may have a large impact in coming years. Bladder cancer is amenable to population modeling
because it has high morbidity, mortality, and cost, is likely preventable by minimizing smoking and toxin
exposure, and the emergence of novel promising biomarkers and treatments. The long-term goal of our
research program is to improve the effectiveness and efficiency of population- and person-level
approaches to bladder cancer prevention, detection, and management given current knowledge and
constraints. The overall objective of the current proposal is to address major questions in the surveillance,
treatment, prevention, and diagnosis of bladder cancer by means of comparative mathematical modeling.
We will address six specific aims: We will (1) complete the development, calibration, and validation of
two independent population models of bladder cancer; (2) explain secular trends in bladder cancer
incidence in relation to trends in tobacco use in key population subgroups and estimate the impact of the
1964 Surgeon General’s smoking recommendations; (3) assess the effectiveness of smoking cessation,
reduction and prevention interventions for the prevention of bladder cancer incidence and mortality; (4)
assess the effectiveness and cost-effectiveness of generic and tailored/patient-centric surveillance policies
for patients with non-muscle invasive bladder cancer; (5) assess the comparative effectiveness of
treatments for organ-confined bladder cancer; and (6) assess the effectiveness of screening for bladder
cancer among high-risk subgroups.

Public health relevance
Narrative We will complete the development, calibration and validation of two independent population models of bladder cancer, and will address major questions in the surveillance, treatment, prevention, and diagnosis of bladder cancer by means of comparative mathematical modeling.